PS-Detect: A Diagnostic Test for Male Fertility/Infertility

Abstract: PS-DETECT: A DIAGNOSTIC TEST FOR MALE FERTILITY/INFERTILITY
The establishment of PS-Fertility, Inc was motivated by: 1) our recent findings from the laboratory that
phosphatidylserine (PS) on the surface of viable sperm is necessary for sperm:egg fusion; 2) that sperm can
fuse with myoblast cells in a PS-dependent manner; and 3) the inability of conventional semen analysis assays
to provide meaningful information about sperm function. Our overall goal of this SBIR is to refine our simple rapid
PS-Detect assay and further develop our business model. This assay will serve to quantify the potential
fertilization-competent sperm in an ejaculate.
Clinicians view semen analysis as a perfunctory assay, rather than an insightful test to acquire information
toward improved assisted reproductive technique strategies. Our market research, performed as part of the NSF
I-Corps program, revealed that, overwhelmingly, clinicians would welcome a diagnostic tool that could provide
new information about male infertility, specifically sperm health/function.
The premise for this application stems our preliminary studies, where we find an unexpected exposure of the
lipid phosphatidylserine (PS), which is normally associated with apoptotic cells, on the surface of viable and
motile sperm. Further, PS recognition receptors are expressed on the oocytes, and blocking/loss of some of
these receptors impairs fertilization.
In this Fast-Track SBIR application, we refine our test called PS-Detect that uses PS as a biomarker for
fertilization competent human sperm. To our knowledge, there are no semen analysis tests that target our
biomarker, nor do any other assays provide information about the potential ability of a sperm to fertilize an egg.
In Phase I we will establish a reference range, demonstrate the feasibility of PS-Detect and become a CLIA
certified lab. In Phase II we will perform a study on the effects of varicocele on PS Score and build classification
models that partition fertile vs sub-fertile samples.
Development of this male fertility test `PS-Detect” will provide fertility experts and thus patients with
information about male fertility that is currently not available from any other diagnostic. This information will aid
in personalizing fertility treatments and reducing emotional and economic costs.

Public health relevance
Public Health Relevance Infertility affects 1 in 6 couples in the United States and ~50% is due to a male cause. Current semen analysis only counts sperm number, assess the morphology and motility, this does not provide information on a sperm's ability to actually fertilize an oocyte. It is widely accepted that if a sperm looks normal, is motile, and there are many of them in a sample, then a male is likely fertile; but this assumption is flawed as many men have normal semen parameters yet are infertile. When male infertility is misdiagnosed the fertility burden subsequently falls onto the female partner. At PS Fertility we are marketing a diagnostic test called PS-Detect that recognizes a biomarker on sperm that is needed for fertilization of an oocyte. PS-Detect coupled with a basic semen analysis will provide a much more complete assessment of male fertility.